Administration and Coordination Core

Administrative and Coordination Core: PROJECT SUMMARY
The proposed Northwestern University Center for Chromatin NanoImaging in Cancer (NU-CCNIC) will bring
together leading cancer research biologists from the Robert H. Lurie Comprehensive Cancer Center in the
Feinberg School of Medicine and world-renowned imaging and molecular modeling specialists from the
McCormick School of Engineering with the goal of facilitating innovation and application of cutting-edge imaging
techniques to help solve some of the most pressing problems in cancer biology research. The Administrative
and Coordination Core (ACC) will be led by PI Vadim Backman. The day-to-day administration of the NU-CCNIC
will be managed by the Center Administrator, who will be responsible for maintaining all records relative to this
award and ensuring communication, synergy, and resource sharing across the NU-CCNIC. Additionally, Center
administration will be supported by a Program Manager, who, in collaboration with the Center Administrator, will
be responsible for the development of the NU-CCNIC website, scheduling meetings and events, facilitating the
sharing of resources, determine whether there will be pre-publication data sharing across the NU-CCNIC, and
aid in conversations about data quality control, cross validation, and reproducibility. An External Advisory Panel
(EAP) will be formed, bringing together investigators with expertise in fields related to cancer stem cell plasticity
and chromatin nanoimaging. The EAP is envisioned as a group of highly active members engaged to advise the
NU-CCNIC leadership on scientific direction and review progress evaluation, research strategies and
implementation, leadership and dissemination, all in the effort to maximize the impact of the NU-CCNIC. The
NU-CCNIC will enhance the translational value and potential impact of its research by engaging a Cancer
Research Advocate, who will be a member of the EAP and will be invited to attend NU-CCNIC workshops and
site visits. The ACC will support weekly, bi-weekly, monthly, and quarterly research meetings to foster
communication, collaboration and integration of the NU-CCNIC and will further support communication and wide-
reaching knowledge dissemination through bi-annual workshops with outside speakers. In Aim 1, the
Administrative Core will promote and ensure clear and effective communication across the Technology
Development (TECH) and Research Test-Bed (RTB) Units. In Aim 2, we will plan and establish regular Center
meetings and research workshops to foster communications within the NU-CCNIC and to the broader community
that are critical to our research mission and dissemination. In Aim 3, we will work to increase representation and
training of underrepresented minorities in the biomedical research workforce of the NU-CCNIC. In Aim 4, we will
partner with the cancer research advocate to ensure the critical importance of the patient perspective in the NU-
CCNIC. In Aim 5, we will work with the EAP and Cancer Research Advocate on NU-CCNIC evaluation programs
to ensure Center progress is accomplished on a timely basis and that resources are allocated judiciously.